Functional Approach to Communication Sound Processing in Mouse Auditory Cortex

PROJECT SUMMARY Auditory research into the neural basis of communication sound processing has generally been conducted without accounting for the social contexts in which communication naturally occurs. Hence, how the auditory system is able detect, discriminate and categorize communication calls despite natural speaker variability is poorly understood, as are the mechanisms by which social interactions affect this processing. Our long-term goal is to uncover the circuit, cellular and molecular mechanisms underlying the auditory system's encoding of socially-acquired vocalizations, so that causes underlying deficits in natural communication processing can be inferred. We pursue this in a mouse model of ultrasound communication wherein two categories of calls (those emitted by mouse pups and by adult males) carry different meanings and can have different levels of behav- ioral relevance to a female. The objective here is to uncover how the representation of these call categories is transformed by hierarchical processing from a primary to a higher-order auditory cortical field, and how differ- ent natural social experiences with the calls produce coding changes. Our central hypothesis is that the trans- formation refines call coding to facilitate communication tasks, and that social experience and neurochemical systems modify this neural transformation as behavioral relevance is acquired. The rationale for this research is that once we know the manner by which neural plasticity in auditory cortex shapes the coding of behaviorally relevant calls, we will be able to exploit the transgenic advantages of the mouse model to dissect the detailed mechanisms enabling these changes. Using extracellular electrophysiology in awake mice, we will test our hy- pothesis with three specific aims. First, we will determine how the neural transformation normally functions to refine the encoding of behaviorally relevant calls by recording from animals that recognize the significance of pup calls (mothers). Second, we will determine how social experience with pups modifies this neural transfor- mation by recording from virgin females that help care for pups (co-carers). Third, we will determine how a key social neurochemical implicated in pup call recognition, estrogen, works with pup care experience to modify the neural transformation by recording from hormonally manipulated co-carers. This proposal's significance lies in its unique ability to bridge the scientific gap between sensory and social/behavioral neuroscience in an animal model in which we can pursue future studies of a high level auditory function (communication) from a system down to a molecular level.

Public health relevance
PROJECT NARRATIVE This research will enable us to discover mechanisms underlying the natural functioning of the processing stream between a primary and higher-order auditory cortical field in the context of species-specific communica- tion. By elucidating the normal operation of this system, our results will be important in implicating aspects of communication coding and plasticity that may fail in auditory processing disorders, social disorders with audi- tory dysfunctions, hearing loss and temporal lobe strokes. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Acoustic communication disorders impair social interactions [168], yet the social aspects of communication dysfunctions and functions are often overlooked in the study of communication sound processing. Indeed, au- ditory research has made progress elucidating the cortical encoding of sound features found in complex voca- lizations [3,57,192]. However, we still do not fully understand how cortical neurons detect, discriminate or cate- gorize calls in the presence of natural feature variability from different speakers or social contexts. The role so- cial interactions themselves play in fine tuning this encoding is also unknown. Cortical plasticity might enhance features predictive of behavioral relevance [174,182,199], but whether it does so during natural communication has not been explored. Hence, it remains to be seen how the auditory cortex processes acoustically variable yet semantically invariant vocalizations whose behavioral meaning is acquired in social contexts. We have sought to address this problem in a mouse model. We focus on two acoustically overlapping but distinguishable ultrasound (US) calls that carry different meaning for a female mouse [124]. The first is a court- ship call produced by adult males when a female is nearby; it keeps the female close [204]. The second is a distress call emitted by displaced pups; even without visual or olfactory localization cues from pups, the calls can direct a search and retrieval by motivated mothers [51,84]. Whereas virgin females innately recognize male calls [87], pup calls are not recognized unless the female gains sufficient experience with pups or be- comes a mother [55]. Also, studies show that estrogen, a key neurochemical for social behavior [34], can aug- ment the experience-dependent acquisition and retention of the pup calls' behavioral relevance, even in virgins [54,114]. Hence, our system provides a unique opportunity to investigate how different natural ways of socially acquiring behavioral significance impact a communication sound's auditory coding. We have already shown that pup call encoding in core auditory cortical fields of the awake mouse differs between naïve virgins and mothers for pup call detection [72]. Other work suggests that hierarchical processing via noncore auditory fields further refines the code, [178,180,228], but the functional role of this refinement has yet to be elucidated. Our long-term goal is to understand the circuit, cellular and molecular mechanisms underlying the auditory system's encoding of socially-acquired vocalizations, so that causes underlying deficits in natural communica- tion processing can be inferred. The objective here is to uncover how call encoding is transformed from a core to a noncore field implicated in pup call recognition (dorsoposterior field, DP [65]), and how different social con- texts during exposure to US calls produce coding changes. Our central hypothesis is that the transformation refines call coding to facilitate communication tasks, and that social experience (including call exposure and pup care) and neurochemical systems modify this transformation as social relevance is acquired. The rationale for this research is that once we know the manner by which neural plasticity in core and noncore areas shapes the coding of socially relevant calls, we will be able to exploit the transgenic advantages of the mouse model to dissect the detailed mechanisms enabling these changes. We test our hypothesis with 3 specific aims: 1. Determine how the core to noncore transformation functions to refine socially relevant calls. Our 1st hypothesis (1a) is that the transition from the core ultrasound field (UF) to noncore field DP in a mother in- volves increasing complexity in the neural sensitivity to acoustic features in US calls. We expect more sen- sitivity to prototypical combinations of pup call features over adult call features, and more invariance to nat- ural acoustic variations, thus enhancing both pup call discrimination and detection. Our 2nd hypothesis (1b) is that the social pup care context mediates plasticity in mothers for these US calls. We expect mothers will have a higher proportion of neurons with such US feature sensitivity compared to yoked virgins who pas- sively hear the same calls in their own home cage without caring for pups. However, neurons from mothers and yoked virgins will respond similarly to behaviorally irrelevant sounds from a nonsocial context. 2. Determine how social experience modifies the core to noncore transformation of socially relevant calls. Our hypothesis is that gaining recent experience living with and "co-caring" for pups (assayed by re- trieval), and acquiring call recognition (assayed by preferential phonotaxis) will change responses in UF and DP of gonadally intact virgins to enhance neuronal discrimination and detection of pup calls compared to yoked virgins who passively hear the same USs in their own cage, but without caring for pups. 3. Determine how a key social neurochemical works with experience to modify the core to noncore transformation of socially relevant calls. Our hypothesis is that priming an ovariectomized (ovx) virgin with estrogen will maintain changes in the processing of pup calls heard in the co-caring context (but not passive exposure context) over a longer period compared to an ovx virgin with social pup experience. Positive impact: This research will enable us to discover mechanisms underlying the natural functioning of the processing stream between a core and noncore area in the context of species-specific, communication. The results will be important in elucidating the aspects of communication coding and plasticity that may fail in audi- tory processing disorders, social disorders with auditory dysfunctions, hearing loss and temporal lobe strokes.